Management and Support of an Archives and Repository Contract (AARC) for the National Toxicology Program (NTP) and the National Institute of Environmental Health Sciences (NIEHS): ARCHIVES

As specified in the contract, the Contractor shall provide space, equipment, services, qualified professional, technical and administrative/clerical personnel, materials, equipment and operational support necessary for operation of an Archives facility for research programs of the NIEHS Division of the National Toxicology Program and Division of Intramural Research.